Administrative Core

For this P01 to fulfill its goal to significantly impact critical barriers to progress in the field of oxytocin as
a disease-modifying agent for pain after injury, it needs strong organization and cohesiveness. The
Administrative Core will coordinate the activities of the P01 among 9 investigators across 3 institutions through
interaction with the P01 leadership structure. The mission of the Administrative Core is to facilitate and assure
the application of high-quality standards throughout the P01, to track progress and provide a structure for
resource allocation, and to provide a mechanism for resolving problems and assuring integration. We will apply
innovative approaches, including documentation of a priori experimental design, assumptions, and data
analysis for all preclinical Projects, akin to trial registration in the clinical realm, application of REDCap
databases to all preclinical and clinical Projects to allow timely, automated reporting of progress, and
application of a newly created variant of StatReviewer to scan manuscripts prior to submission for key
elements of transparent reporting requirements. The Administrative Core will serve the following primary aims
and functions:
Aim 1: Facilitate day to day activities, internal quality control, and review of progress
The Administrative Core will coordinate resource sharing, including major equipment, animal husbandry, and
surgical facilities within the Pain Mechanisms Laboratory. It will establish a REDCap database for all preclinical
and clinical activities and generate monthly automated reports. Finally, it will establish the equivalent of trial
registration for preclinical studies.
Aim 2: Identify and address needs for changes in course or conflict resolution
The Administrative Core will provide resources and structure for decision making regarding the two main
reasons for course correction – technical / interpretation stumbling blocks and new knowledge from inside or
outside the P01, through review of automated reports and regular meetings, an interactive review of new
publications, and advisory and scientific symposia. The Administrative Core will coordinate meetings of the
P01 leadership structure to prevent and resolve conflicts.
Aim 3: Coordinate dissemination of concepts developed uniquely by the P01
The Administrative Core will facilitate integration and impact of the synergy provided by the P01 through
regular discussions of publication and presentation strategies and through internal review of these products
prior to release, including scanning for transparent reporting requirements. It will also coordinate presentation
of P01 research and progress to the External Advisory Committee and organize an annual symposium.

Public health relevance
The Administrative Core coordinates all activities of the P01 across 9 investigators and 3 institutions. This includes assurance of high-quality standards and rigorous approaches, tracking progress, providing a structure for resource allocation, and providing mechanisms for resolving problems and assuring integration across all projects and cores.